ZEB1 Mediated Coronary Artery Disease Risk in Vascular Smooth Muscle

PROJECT SUMMARY
Coronary artery disease (CAD) is the leading cause of death worldwide, but therapeutic options beyond lipid
lowering strategies remain lacking for due to the critical knowledge gap linking genetic risk factors to disease
mechanisms. Smooth muscle cells (SMCs) play a critical role in atherosclerosis development. These cells
undergo a phenotypic transition process, where they dedifferentiate and migrate out of the blood vessel media
and contribute to the fibrous cap. Furthermore, SMCs have been identified as the primary source of genetic
susceptibility to CAD. Dr. Daniel Li’s (PI) preliminary data prioritizing transcription factors involved in
phenotypic transition using probabilistic cell fate mapping has identified the ZEB transcription factor
family (ZEB1 and ZEB2) as key genes driving this process. ZEBs regulate cell proliferation and plasticity,
while human genetics has associated both genes with CAD risk. The genetic risk signal near ZEB2 can be
explained by its role as an epigenetic regulator of SMC fate. However, the cellular mechanism(s) by which ZEB1
influences disease risk are unknown. ZEB factors share conserved DNA binding domains but have low homology
in protein interaction domains, allowing the recruitment of diverse epigenetic regulators. Furthermore, they have
reciprocal cellular transcriptional profiles in atherosclerosis-relevant cell types.
The primary objective of this proposal is to characterize and establish the causal role of ZEB1 in
atherosclerosis development. The central hypothesis is that ZEB1 acts as a counter-regulatory factor to ZEB2
via epigenetic mechanisms to maintain a differentiated smooth muscle state in the setting of vascular wall stress.
Aim 1 will use a translational Zeb1 knockout mouse model to determine the transcriptional, epigenetic, and
plaque phenotype of SMC lineage cells. Aim 2 will use functional genomics and proteomics to determine how
ZEB factors differentially regulate SMC transcriptional processes via epigenetic mechanisms. The results of this
study will elucidate the underlying mechanisms by which two novel but potentially counter-regulatory CAD genes
drive the phenotypic transition of SMCs.
In parallel, Dr. Li will complete a comprehensive training plan to 1) advance his background in bioinformatic tools
for genetics and genomics, 2) develop expertise in the use and applications of proteomics, 3) build upon scientific
and communication skills, and 4) further develop his scientific writing and grantsmanship skills and transition to
academic research independence. This research proposal will be guided by Dr. Quertermous, a world leader in
cardiovascular genetics, and an advisory committee consisting of world-renowned experts in computational
genomic methods, proteomics, cardiovascular epidemiology, and vascular biology. Through this project, Dr. Li
will develop the skillset to become an independent investigator dedicated to deciphering the genetic risks in
atherosclerosis and translating these findings towards clinical practice.

Public health relevance
PROJECT NARRATIVE This study will investigate ZEB1’s mechanistic role in modulating cardiovascular risk by utilizing state-of-the-art single-cell, functional genomics, and proteomics analyses in animal and human models. By elucidating ZEB1’s interactions with other coronary artery disease-associated genes, we aim to develop enhanced risk stratification tools and precision therapeutics. These findings will inform novel strategies for preventing heart attacks and improving overall cardiovascular health.